Stimulating the vagus nerve to improve gait in Veterans with Parkinson's disease

More than 110,000 US Veterans living with Parkinson’s disease (PD) currently receive PD-related care and
services from the VA. PD is a complex chronic neurodegenerative multisystem disorder. Fall prevention is a
priority for Veterans living with PD. Gait disturbances are a major cause for functional dependence and the
largest risk factor for falls, institutionalization, and death in PD. Gait abnormalities are evident at the time of
PD diagnosis and are one of the most disabling features of PD. They are also difficult aspects to treat as
pharmacologic agents do not address the entire spectrum of gait abnormalities. Overall management of PD
symptoms can be challenging due to pharmacological interactions and drug side effects. Developing a non-
pharmacological and non-invasive therapeutic to improve gait and balance is a critical need for Veterans with
PD who are managing complex chronic conditions. Moreover, advancing at-home rehabilitation is ideal for a
population of geriatric Veterans who are facing mobility issues, managing multiple chronic conditions and who
rely on caregiver support. Non-invasive cervical Vagal Nerve Stimulation (ncVNS) may be a solution. ncVNS is
currently licensed to treat and prevent migraine and other headache syndromes and is covered by the VAH for
these indications. ncVNS can be self-administered, daily, at home. A hand-held device is used to make contact
to the left side of the neck so that the vagal nerve is stimulated. ncVNS decreases inflammation and oxidative
stress through activation of the cholinergic anti-inflammatory pathway, which in turn can contribute to gait
improvements in PD. One of the most debilitating gait deficits in PD is Freezing of Gait (FOG), an episodic
failure to initiate or maintain walking, especially while turning. Given that FOG, along with falls, is related to
cholinergic dysfunction, both might be reduced following ncVNS. Exciting, but limited research over the past
decade indicates this neuromodulatory approach has the potential to improve gait features in PD. The
objectives of this SPiRE are to develop a framework for an at-home ncVNS intervention, develop an
appropriate control intervention for a future larger study and gather preliminary clinical outcome data on
PD-specific features. The central hypotheses are that (i) a 4 week at-home active ncVNS intervention and a
sham ncVNS control condition will be acceptable and feasible to complete and (ii) active ncVNS compared to
both control ncVNS and treatment as usual (TAU), will lead to greater improvements in gait, FOG, balance and
fall frequency. The proposed study is a pilot, prospective parallel group randomized control trial (RCT). Twenty
participants will be randomized to 4 weeks of either active (n=10) or sham ncVNS (n=10). A third group
(n=10) will not receive ncVNS but will continue with their treatment as usual (TAU). We will examine acute,
cumulative, and sustainable effects of ncVNS. Advancing non-pharmacologic treatments to improve gait
dynamics is a critical need for Veterans with PD. Moreover, advancing at-home rehabilitation is ideal for a
population of geriatric Veterans who are facing multiple issues including mobility. This SPiRE is strongly
aligned with VA priorities to advance rehabilitative health care of Veterans and restore their physical function
to improve QoL. If the aims are achieved, we will have completed necessary first steps towards developing an
at-home easy to use, neuromodulatory intervention that should translate to improved gait and balance and
contribute to fewer falls. This project will yield preliminary data to support a VA Merit and move forward not
only the field of noninvasive and nonpharmacological interventions for PD rehabilitation but also the general
field of gait and balance rehabilitation.

Public health relevance
More than 110,000 US Veterans living with Parkinson’s disease (PD) currently receive PD-related care and services from the VA. Fall prevention is a priority for Veterans living PD. Gait disturbances are a major cause for functional dependence and the largest risk factor for falls, institutionalization, and death in PD. This SPiRE addresses the need to advance nonpharmacological rehabilitative health care of Veterans and maximizing functional outcomes by developing a non-invasive, neuromodulatory transcutaneous cervical Vagal Nerve Stimulation as an at-home intervention to improve gait and balance. This pilot clinical trial will assist with future efforts and priorities of the VA to prolong independent living and quality of life by minimizing gait and balance dysfunction experienced by Veterans living with PD.